MULTICENTER TRIAL IN PERIODIC PARALYSES AND ASSOCIATED SODIUM DISORDERS

To determine the efficacy of dichlorphenamide in the treatment of episodic attacks of weakness in the periodic paralyses. This protocol has now been terminated.